Clinical Core

PROJECT SUMMARY: CLINICAL CORE
The objective of the C-SiG Clinical Core is to provide a user-friendly, one-stop service to access digestive
disease-related biospecimens for Center members. Under the direction of Dr. Lisa Boardman, a well-
established clinician scientist with IRB, application of constitutional and somatic molecular genetics and their
impact of molecular pathways associated with disease and health, and biobanking expertise, the organization
and infrastructure of the C-SiG Clinical Core provides essential expertise and personnel to advise and interact
with C-SiG members in pursuit of two Specific Aims: First, to expedite access to GI biospecimens for C-SiG
members from study design development to identification of appropriate clinically and molecularly annotated
specimens. Second, to enhance existing individual GI-related biobanks operating within the Clinical Core
umbrella and develop new repositories. To achieve these aims the C-SiG Clinical Core: i) Integrates existing
tissue collections and annotated data into a collaborative web-based organizational structure that is easily
accessible by C-SiG members; ii) Expedites institutional IRB protocol/biospecimens committee approval and
coordinates priority access for C-SiG members to expert intramural biospecimens processing services; iii)
Facilitates the initiation of new biobanks that will focus on new diseases or types of biospecimens not currently
collected by existing biobanks with an emphasis on accruing diverse patient samples; iv) Develops best
practices for biospecimen processing and procurement in anticipation of tissues that will be optimal for
emerging technologies (e.g., cryopreservation for single cell isolation). The Core integrates existing resources
from individual investigators in GIH and from institutional biospecimens repositories, providing a cost-effective
approach to collaboratively translate GI signaling paradigms into human tissues. Additionally, the C-SiG
Clinical Core has developed strong partnerships with the IRB, anatomic pathology (aka TRAG; source of all
surgical biospecimens), the Pathology Research Core (tissue sectioning), the Center for Individualized
Medicine (whole exome sequencing data through the Tapestry Study) and the Mayo Biobank (blood based
biospecimens, FFPE tissues, and epidemiologic information). The primary services offered by the C-SiG
Clinical Core are IRB protocol development support, biospecimens request support, and biobank support
services. We support the collection of stool for human microbiome research and have developed an organoid-
related service line. We are developing molecular phenotyping and we will enhance the Institutional initiative
for digitalization of all clinical tissue slides by digitalization of C-SiG members research generated slides to
create a digital atlas repository which will both inform sample selection for future C-SiG members’ use and
provide the infrastructure for hypothesis generating and agnostic studies connecting molecular and histologic
features and disease states and outcomes. The C-SiG Clinical Core services have been used by 61% of
the current Center members and have supported 62 publications in the past 5 years.